California Labor Laboratory (CALL)

Project Abstract/Summary – California Labor Laboratory
The goal of our Total Worker Health Center of Excellence, the California Labor Laboratory (CALL) is to
understand the causes of and prevent or mitigate the health impacts of emergent working conditions. The axes
of change in work include the growth of alternative work arrangements and contingent forms of employment, and
erosion of traditional working conditions. CALL will emphasize the health impacts on those most vulnerable to
the changes, including racial and ethnic minorities; women; immigrants; low wage workers; persons with
disabilities; and younger and older workers, especially those with chronic diseases. Covid-19 has made it clear
just how vulnerable these groups are to the changes. Concern for their welfare motivates the proposed Center.
California not only has the largest population of any state, at just under 40 million, but it is among the most
diverse in its racial and ethnic composition. California has also been a trend-setter in work organization, with
large proportion of the workforce not being directly hired by the firm for which the work is done.
CALL has these specific aims: 1) To describe, through RESEARCH, the prevalence of alternative work
arrangements, document the etiological connection between those work arrangements, important sentinel
working conditions, and adverse health outcomes, and perform research to uncover the mechanisms that
translate work arrangements into poor health; and 2) To mitigate the health impacts of alternative work
arrangements through a robust OUTREACH program encompassing the development of an interdisciplinary
training program for healthy work based on research from CALL, consulting to workers and employers on best
practices, and working with policymakers in regulatory, executive, and legislative branches of government at the
State and Federal level to develop legislation to improve the health of work through the POLICY FORUM.
CALL is a joint endeavor of two of the premier research universities in the nation, the University of California at
Berkeley (UCB) and San Francisco (UCSF), but includes participants from Harvard, UCLA, and the State
Department of Public Health. Several projects will jointly sponsor and use a longitudinal survey of 5,000 working
age Californians to study the effect of emergent work organization and workplace exposures on health and to
develop and test a multidimensional tool to evaluate the health of employment. Additional projects will use a
customized sample of service workers to study the impact of inequality in working conditions and the State’s
public health surveillance powers to gauge the impact of employment in the stone fabrication industry on the
health of its largely immigrant workforce. CALL’s EVALUATION and PLANNING CORE develops strategic
direction for the Center, manages its operations, and evaluates its progress. The activities of the Center are
guided by a distinguished EXTERNAL ADVISORY COMMITTEE. The COMMUNITY ENGAGEMENT BOARD
will bring the perspectives of the State’s diverse population into the design and implementation of the Center’s
research and outreach activities to reduce impacts on vulnerable populations.

Public health relevance
Project Narrative – California Labor Laboratory The goal of our Total Worker Health Center, the California Labor Laboratory, is to describe, understand the causes of, and prevent or mitigate the health impacts of emergent working conditions, with a special emphasis on those vulnerable to those conditions, including members of racial and ethnic minorities; women; immigrants; low wage workers; persons with disabilities; and younger and older workers, especially those with existing chronic diseases. California not only has the largest population of any state, at just under 40 million, but it is among the most diverse in its racial and ethnic composition and in the mix of its industries and it has also been a trend-setter in work organization, with large proportion of the workforce not having a full-time, full-year job at a single workplace and not being directly hired by the firm for which the work is done. The proposed Center has a comprehensive research program of five projects focused on the health impacts of changes in working conditions and a comprehensive outreach program consisting of interdisciplinary training for health professionals and the public, development of a cadre of researchers devoted to understanding the health impacts of emerging work through a pilot grants program, consulting to groups of workers and firms on best practices for healthy employment, and development of a public policy agenda and engagement with policymakers to address the adverse impacts of working conditions through law and regulation.